Human Microbiome Data Discovery: A short course on unveiling microbial insights to human health through Common Fund Data

Project Summary
The overarching objective of this R25 program is to develop the curricular materials for teaching essential data
science skills to early career scientists interested in microbiome research to enable them to access and use
data available in the Common Fund Data Ecosystem (CFDE). Although there is an enormous potential for the
large datasets available through the CDFE to advance biomedical research, our broad needs assessment has
identified that a wide range of researchers lack fundamental skills necessary to use these types of data. Gaps
we have identified include identifying the appropriate data sets to answer hypotheses, managing, wrangling,
and harmonizing data in preparation for analysis, in addition to performing the analyses. We propose to close
this gap and accomplish our objects by: 1) Performing a needs assessment of potential Common Fund Data
users, targeting early career clinically oriented faculty developing research related to the human microbiome.
2) Developing curricular materials for knowledge and skills in data science using three datasets developed by
NIH Common Fund projects related to the human microbiome, microbial products, and clinical associations. 3)
Delivering a two-week in-person short course on data science to a diverse set of early career learners to
educate and provide skills necessary for accessing data in the Common Fund Data Ecosystem and
incorporating these data sources into research. And 4) Providing extended support beyond the short-course
through informatics mentorship to support common fund data use in participant’s area of research. The
program will be led by experts in Biomedical Informatics Education and Microbiome Bioinformatics and be
supported by several faculty with expertise and extensive educational experience in data science, clinical
informatics, artificial intelligence and machine learning, data visualization, and data management. The short
course will focus on applications of CFDE to address research questions related to the human microbiome in
human health and disease, with a specific focus on diabetes. We anticipate the impact of this program to be
substantial in enabling researchers to improve their use of existing CFDE projects into their own research more
rapidly and accurately. We will disseminate this work broadly through online resources so that others may train
their own teams.

Public health relevance
Project Narrative The large datasets that are available in the Common Fund Data Ecosystem provide remarkable opportunities to advance our understanding of factors that contribute to human health and disease. This project aims to develop and disseminate curricular material to provide researchers with the necessary data science skills to access and use data from the Common Fund Data Ecosystem to understand the relationship between the human microbiome and health and disease.